Yale Pathology Tissue Services Shared Resource

YALE PATHOLOGY TISSUE SERVICES SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
Yale Pathology Tissue Services (YPTS) is committed to providing the maximum amount and quality of human
tissue for research at Yale Cancer Center and Yale University without impacting diagnostic quality, accuracy,
and safety in anatomic pathology. YPTS, established in 2007, based in the Department of Pathology, serves as
a shared resource for YCC. The resource includes 3 divisions that work together to provide a full range of tissue
services: Tissue Distribution and Analysis (TDA), Developmental Histology and Tissue Microarrays (DH-TMA),
and Clinical Trials Tissue Services (CTTS).
The Tissue Distribution and Analysis (TDA) has about 40 active standard operating procedures (SOPs) for tissue
acquisition, over half of which provide tissue to members of YCC including a series of federated tissue banks
including specific disease-focused biorepositories for the Lung and HNSCC SPORE biobanks. Two of these
SOPs are for the new Yale Biobank (a new University-wide, centrally supported tissue bank expected to replace
the federated tissue banking system in the future). We anticipate that over the next 5 years the federated
disease-specific biorepositories will transition to the central Yale University Centralized Biobank with more
streamlined tissue collection SOPs. The TDA division also provides slide scanning and quantitative analysis
services for Yale investigators.
The Developmental Histology (DH) division provides comprehensive human and animal histology services,
including chromogenic immunohistochemistry, bespoke fixation and processing, frozen sections, TMA
construction and distribution and access to the Yale Pathology archives for historical diagnostic tissue. DH/TMA
has nearly 600 master blocks, some with as many as 20 replicates, and distributes around 50,000 TMA slides
per year.
Clinical Trials Tissue Services (CTTS) provides rapid access to FFPE tissue for patient enrollment in trials
requiring tissue samples both within Yale and for outside institutions.
The YPTS resource has been directed by David Rimm, MD, PhD, since 2007 and he has a 5-member leadership
team that help manage 15 FTEs. The services are ordered online and create an auditable record of operations
supported by a dedicated computational programmer from the Department of Pathology’s IT unit. The software
was built at Yale and is maintained and updated by the computational supervisor (Sudha Kumar) including
“eHisto”, the tissue and services ordering and accounting system and “Aquamine”, a PHI-free database allowing
public access to data obtained from TMAs and whole slide cohorts available from YPTS.

Public health relevance
YALE PATHOLOGY TISSUE SERVICES SHARED RESOURCE – NARRATIVE Not applicable.